Administrative Core (Core A)

PROJECT SUMMARY
Administrative Core (Core A)
The Administrative (Admin) Core is the central coordinating hub for the University of Alabama at Birmingham
(UAB) Center for AIDS Research (CFAR). Through effective leadership, an integrated organizational structure,
comprehensive financial and management planning, and strategic implementation, the Core propels CFAR
investigators to reach their highest scientific potential. The Core fosters an environment and culture to serve the
CFAR scientific mission, thereby adding value beyond what can be achieved via research grants to individual
investigators. Our structure – including 5 Cores (Administrative, Developmental, Clinical, Advanced Technology,
Implementation and Community Sciences) and 2 Scientific Working Groups (SWG, Substance Use, Global Health
Reciprocal Innovation) – and strategic planning processes are enveloped by our shared values of growing
diversity, equity, inclusion, and access to our research and being in authentic partnership with communities most
impacted by HIV. Through the development of HIV investigators and cultivation of interdisciplinary research
collaborations, the Core plays a critical role in the growth of HIV research at UAB, which currently has funding
of $66 million for HIV research in 2022, including $23 million in our NIH HIV funded research base (FRB).
Continuous monitoring and assessment conducted by the Administrative Core ensures that the aims of all Cores
and SWGs are fully aligned with the strategic objectives and shared values and that services and activities are
implemented effectively within defined timelines.
During the next funding cycle, the Core will achieve three aims:
1) Provide scientific leadership and governance based on thoughtful strategic planning and ongoing monitoring
to add value and proactively identify avenues for continuous growth;
2) Nurture synergies to stimulate inter-disciplinary research and promote multi-disciplinary educational and
training opportunities in HIV research; and
3) Foster community outreach and support initiatives by CFAR and community partners to enhance meaningful
partnerships and advance HIV research that is top priority for the community
These aims will be accomplished through active engagement of a highly effective, coordinated leadership team
housed within the Administrative Core.